SYNTHESIS OF TUMOR INHIBITORY COMPOUNDS

This renewal proposal outlines five specific objectives in the chemistry and pharmacology of antitumor, antileukemic, antifungal and antibiotic natural products. Plans include chemical and biosynthetic investigations of naturally-occurring highly oxidized cyclohexanes, as well as total syntheses of complex quassinoids, the fungal metabolite LLZ-1220, and Beta-lactam structures such as thienamycin and the monobactams. Studies will also be initiated in collaboration with investigators at Vanderbilt University School of Medicine on the oxidative metabolism of Dilantin (diphenylhydantoin), a potent anticonvulsant and antiepileptic agent. Our long-term objectives include the preparation of new biologically active compounds and drug analogs for pharmacological evaluation.